Point-of-Care Rapid RNA Diagnosis of Influenza Virus

? DESCRIPTION (provided by applicant): Influenza rapidly spreads around the world in seasonal epidemics and imposes a considerable economic burden in the form of hospital and other health care costs and lost productivity [1, 2]. Early prediction, detection, characterization and risk assessment of viruses in their animal hosts, before they spread into the human population, are critical to protect public health [3, 4]. Global burdens from existing or emerging infectious diseases emphasize the need for a point-of-care (POC) diagnostics to enhance timely recognition and intervention [5]. To better prepare for the next pandemic, we need to develop simple and easy-to-use tests for characterizing newly emerging influenza viruses and needs of point of care flu diagnostic devices at low cost with a multiplex platform [5]. A highly sensitive, simple paper strip molecular test that detects the Influenza virus at the point-of-care will be developed.

Public health relevance
PUBLIC HEALTH RELEVANCE: Emerging infectious diseases and pandemics in humans often originate from pathogens transmitted from nonhuman animal reservoirs. The pandemics of severe acute respiratory syndrome, HIV, and 2009 H1N1 influenza illustrate the dramatic impact of viral host- switching on public health and the global economy. Early prediction, detection, characterization, and risk assessment of viruses in their animal hosts, before they spread into the human population, are critical to protect public health. Global burdens from existing or emerging infectious diseases emphasize the need for point-of-care (POC) diagnostics to enhance timely recognition and intervention. We will develop rapid tests for RNA viral pathogens that do not require any instrumentation and PCR.